MOLECULAR GENETICS OF INTESTINAL DEVELOPMENT

The mouse intestinal epithelium undergoes perpetual proliferation and differentiation. This process is geographically well organized by early postnatal life: (i) an anchored, monoclonally derived stem cell population located in each of the intestinal crypts gives rise to the four principal, terminally differentiated, epithelial cell types and (ii) differentiation of the stem cell descendants occurs during a bipolar migration process. During perinatal period, the epithelium undergoes remarkable morphologic and functional differentiation: villi emerge, crypts form from the intervillous spaces and their polyclonal cell population is "purified" to monoclonality; pluripotent stem cells become anchored at the crypt bases; gradients in gene expression are established from crypt to villus and from proximal to distal intestine. There is no in vitro system for examining this spatially complex differentiation process. We will use mammalian genetics in concert with cell and molecular biologic techniques to identify mechanisms which regulate intestinal epithelial differentiation. Genetically diverse inbred strains of normal mice as well as mutant, chimeric and transgenic mice will be employed to address four specific aims. (1) We will use RI strains to map genetic loci which regulate the expression of four cytoplasmic hydrophobic ligand binding protein genes during gut development. These genes are sensitive markers of epithelial cell differentiation. (2) We will examine crypt stem cell purification and epithelial differentiation during late fetal and early postnatal life using mouse aggregation chimeras as well as transgenic mice containing promoters from one of these hydrophobic ligand binding protein genes inked to a human growth hormone reporter. (3) The role of thyroid hormone in regulating gene expression during development of the intestinal epithelium, will be assessed using a mutant strain of mice with a recessive mutation producing congenital hypothyroidism (hyt). (4) The role of a recently cloned gene encoding a trans-acting factor (the CCAAT/Enhancer binding protein) in regulating intestinal epithelial gene expression will be analyzed. This gene was selected because we have shown that it displays remarkable alterations in its expression during the perinatal period of gut development and that its protein product binds to at least two of the hydrophobic ligand binding protein gene promoters.